Novel Myofunctional Nipple to Prevent Obstructive Sleep Apnea in Infants

Project Summary:
There is a clear unmet need to provide a non-invasive and non-burdensome first line treatment and preventive
measure for obstructive sleep apnea (OSA) in infants. Although OSA in infants typically goes undiagnosed, it is
estimated that 1%-4% of infants suffer from OSA affecting as many as 5.6 million infants worldwide each year.
OSA in infant populations can have detrimental impacts on long-term health, including an increased risk for
obesity, developmental delays, hyperactivity, increased blood pressure, a general “failure to thrive,” and even
organ damage. Less severe forms of sleep disordered breathing (SDB) such as snoring, which is prevalent in
10% of infants, can be associated with behavioral issues and diminished cognitive skills which can overall
decrease the quality of life of the infant. A first line treatment in children is adenotonsillectomy (A&T), a surgical
procedure that removes tonsils and adenoids. Although A&T can be effective, it is an invasive procedure that,
due to risk of complications, is rarely conducted on infants below the age of one. Continuous positive air pressure
(CPAP) therapy, the other prominent treatment for OSA, often causes additional issues for infants who already
have respiratory issues, such as increased viral load. Myofunctional therapy consisting of oropharyngeal
exercises is a promising new potential first line & non-invasive treatment of OSA for adults and children. Studies
have shown myofunctional therapy to decrease apnea hypopnea index (AHI) by 14.3 events/hour in adults, 3.0
events/hour (60% reduction) in children, and reduces residual OSA in children after A&T. However, it is difficult
for infants to learn and practice beneficial myofunctional exercises. There is currently no low risk, low burden
device that can be used to treat OSA in infants. Many families feed their children with a bottle starting in the first
six months of the child’s life, and baby bottle use during infancy can be associated with an increased risk for
OSA when compared to breastfeeding: breastfeeding babies exercises oropharyngeal muscles like
myofunctional therapy does. However, there are currently no baby bottles that incorporate oropharyngeal
exercises into the daily drinking and feeding of infants. There is a huge opportunity to deliver oropharyngeal
exercises to improve OSA in a baby bottle format. To address the lack of low risk and low burden solutions for
infant OSA, we will develop an innovative myofunctional therapy baby bottle nipple and that can be easily
administered to infants with OSA. The scientific premise of this project is that a novel therapeutic myo-nipple that
mimics breastfeeding forces will both reduce the prevalence of infant OSA and prevent the long-term
development of OSA by stimulating proper craniofacial growth and orofacial muscle development. Parents and
clinicians will be interviewed to understand the requirements for successful market entry of the baby bottle myo-
nipple. This will be followed by the development of a functional myo-nipple prototype that meets the requirements
from clinicians and parents and incorporates defined breast-like oropharyngeal exercises. This project seeks to
improve the quality of life for future generations of would-be OSA sufferers and primary snorers.

Public health relevance
Project Narrative 1-4% of American infants suffer from obstructive sleep apnea and 10% from snoring resulting in serious implications for overall health such as increased risk for obesity, developmental delays, hyperactivity, hypertension, and “failure to thrive” or lack of growth. This project aims to demonstrate a low risk, low burden, and affordable myofunctional therapy nipple and bottle that can easily be administered to infant OSA patients to reduce the overall harm from these conditions.